Proteomic Analysis of Implant Surfaces in Athroplasty Failure

PROJECT SUMMARY
Our team has developed a strategy that samples materials on surfaces of removed orthopedic implants using
sonication and shown that the derived biofilm-sampling “sonicate fluids” have the highest yield of any specimen
type for microbial detection and can furthermore be used to assess host response at implant surfaces. While
assessment of host response has been clinically leveraged to differentiate infected from non-infected orthopedic
implants, host-based approaches deployed to date have been simplistic, detecting alpha-defensin or profiling
neutrophil numbers, for example, with none defining the microbiology of infected arthroplasties or underlying
etiologies of non-infectious arthroplasty failure. We hypothesize that, beyond differentiating infectious from
non-infectious arthroplasty failure, capturing host response in sonicate fluid using a proteomic
approach will discern microbial etiologies of periprosthetic joint infection and individual causes of non-
infectious arthroplasty failure. Given that detection of causative organisms in periprosthetic joint infection and
definition individual causes of non-infectious arthroplasty failure, needed to direct management, are not
universally realized with extant diagnostic approaches, this will be clinically useful.
We propose the first-ever global, unbiased proteomic analysis of sonicate fluid, assessing in vivo human immune
response to infectious compared to non-infectious arthroplasty failure and subsets thereof. We further propose
an unbiased global analysis of microbial proteins in sonicate fluid in periprosthetic joint infection. Sonicate fluid
has been shown in preliminary work to be suitable for the proposed proteomic analyses. Sonicate fluid from
failed total knee arthroplasties will be studied using the new technology of liquid chromatography tandem
mass spectrometry to determine whether host proteomic analysis can differentiate Staphylococcus aureus,
Staphylococcus epidermidis, Staphylococcus lugdunensis, Enterococcus faecalis and Streptococcus agalactiae
periprosthetic joint infection, and non-infectious arthroplasty failure subsets of aseptic loosening, periprosthetic
fracture, instability, and osteolysis/adverse tissue reaction. In addition to mass spectrometry, a complementary
next generation sequencing-based proximity extension assay approach that measures levels of 3,072
cytokines and other host proteins will be used to measure low abundance human proteins missed using
mass spectrometry alone, allowing examination of host response in even greater detail. Finally, microbial
proteomic analysis of sonicate fluid from patients with periprosthetic joint infection will be performed, to determine
whether microbial proteomic analysis can differentiate S. aureus, S. epidermidis, S. lugdunensis, E. faecalis and
S. agalactiae infections.

Public health relevance
PROJECT NARRATIVE Our goal is to improve understanding of the causes of infections of joint replacements and non-infectious causes of arthroplasty failure. We are targeting the microorganisms that cause infections directly as well as host response to them and to other causes of arthroplasty failure using a proteomic strategy applied to materials dislodged from the surfaces of knee replacements. Our prior work has led to new diagnostic techniques that are now part of standard guidelines; our new studies, proposed here, are poised to lead to even better diagnostic tests and to inform future treatment and prevention approaches for arthroplasty failure.